A HUMAN IPSC-BASED ORGANOID PLATFORM FOR STUDYING MATERNAL HYPERGLYCEMIA-INDUCED CONGENITAL HEART DEFECTS

Congenital heart defects (CHD) are the most common type of birth defect, with cardiac malformation resulting
from abnormal heat development contributed by genetic and/or environmental risk factors. The association of
maternal diabetes with increased offspring CHD incidence is proposed to be attributed to factors including
glucose imbalance and metabolic dysregulation. Murine studies on hyperglycemia have been beneficial in
uncovering the phenotypic effects of maternal hyperglycemia on embryonic development, with reports that high
glucose conditions are associated with general suppression of WNT signaling, apoptosis, and excessive reactive
oxygen species (ROS) production. However, little is known about the effects of hyperglycemia on human stem
cells in regard to cardiomyocyte determination, metabolism, and functionality. Additionally, there is little reports
of these alterations using induced pluripotent stemcells (iPSCs), which provide an opportunityto observe cardiac
progenitor cell (CPC) heterogeneity, multicellular crosstalk, and differentiated cell functionality at key
development timepoints. We hypothesize that high glucose environments interfere with normal cardiac
differentiation to cause altered cell lineage determination in iPSCs and iPSC-derived cardiomyocytes (iPSC-
CMs). We propose use of immunofluorescence assays and staining to quantify mitochondrial metabolism,
mitochondrial ROS production, and apoptosis marker amounts. Our goal is to investigate the impact of high
glucose on human cardiomyocyte differentiation and crosstalk signaling abnormalities during 3D stem cell
differentiation that could lead to impaired cardiac development. We will investigate differentially expressed genes
at the single-cell resolutionin early and late differentiation in responseto high glucose doses in iPSC populations.
Should our transcriptional profiling comparisons yield iPSC and iPSC-CM expression differences, the resulting
phenotypes would provide insight into cardiac cell determination during hyperglycemic conditions.
Understanding the hyperglycemia-response mechanisms is important in the onset of maternal hyperglycemia-
associated CHD. These mechanisms would be further investigated through looking at cell lineage population
composition in organoids and analyze response per lineage to narrow down what structures of the mature heart
are affected.

Public health relevance
Congenital heart disease (CHD) is the most common type of birth defect. Pregnant mothers with higher-than- normal blood sugar are associated with a higher CHD risk, and little is known about disturbances to energy processing and stem cell development involved in human heart cells. Using body cells reprogrammed into stem cells called human induced pluripotent stem cells (iPSCs), we propose observing stem cell maturation and metabolism in iPSCs to investigate how high blood sugar drives CHD in diabetic mothers and to better understand how CHD develops.